The Unilateral Mosaic (UMos): Novel tools to compartmentalize pathology and trace cellular interactions in mouse models of human disease

This project will credential two novel types of broadly applicable mouse models, which we will demonstrate in
the lung. First, we will express genes that drive disease susceptibility on one side of the lungs only, a model we
call a Unilateral Mosaic, creating disease-prone and disease resistant (internal control) lung tissue in a single
animal. The lungs serve as a proof-of-concept organ, but this Unilateral Mosaic model applies to other
asymmetric or paired organ systems such as the liver, and also to the limbs. The second type of engineered
mouse will harbor an allele that installs permanent genetic marks within niche or neighbor cells, for in vivo cellular
contact tracing in mice. Using a secreted and cell-permeant Tat-Cre protein, cells will be targeted for
recombination in vitro using co-culture and media transfer experiments, and in vivo using transplantation of
engineered Tat-Cre expressing cells into loxP-activated fluorescent reporter mice. There is an urgent need for
mouse models that reduce animal to animal variability, and increase the in vivo resolving power for tracking
cellular behavior. The models we present begin to address these challenges, and will appeal to a wide variety of
investigators that employ mice to study complex human diseases. The proposed genetic tools are designed to
address numerous categories of biological problems in living animals, but are not intrinsically confined to a
specific disease state or organ. These studies employ the well-established Cre-LoxP system for targeted in vivo
gene expression, applicable to the numerous floxed alleles in existence. This work will broadly impact the
available applications for tissue- or lineage-specific expression of genes in mice, enabling investigators to track
cells or induce gene expression in neighboring or transacting cells that contact driver cells of a given lineage.
Specific Aim 1. Generate a Unilateral Mosaic model of disease susceptibility.
a. Test whether human Ace2 excision can restrict SARS-CoV2 infection to one side of the lung.
b. Determine whether excision of Cox2/Ptgs2 unilaterally in the lungs can compartmentalize metastatic disease
after intravenous injection of metastatic mouse mammary cancer cells.
Specific Aim 2. Test and deploy a Tat-Cre allele for in vivo lineage contact tracing
We anticipate this project will yield rapid results, as we already have the ASE-Cre Unilateral Mosaic driver mice
in house and have exciting preliminary data to reveal the target organs for its asymmetric expression. We have
performed many SARS-CoV-2 viral challenge studies in human Ace2 knockin/knockout mice with a currently
approved and active animal BSL-3 program in the lab. In addition to our experience in mouse mammary tumor
models and lung developmental and cancer biology in mice, we have established collaborations to ensure the
success of syngeneic mammary tumor transplant studies. For Aim 2, we already have cloned and present
preliminary data to demonstrate the utility of the new Tat-Cre construct. In summary, we have the required
experience and existing preliminary data and materials to bring the proposed studies to a successful completion.

Public health relevance
Project Narrative A major challenge in modeling human disease in animals is the variability in outcomes among individual animals, especially where disease mortality or morbidity limits downstream analyses of affected organs. We have designed new genetic tools to cause disease on only one side (left or right) of paired visceral organs and limbs, focused here on a proof-of-concept in the lungs using mouse models of viral pneumonia and cancer metastases. Our studies will provide new tools to cause disease and track cells in live mice, laying the groundwork for exciting applications in diverse mouse models spanning respiratory disease, arthritis, cancer, hepatitis and many others.